EFFECT OF ALENDRONATE, ESTROGEN AND COMBINATION THERAPY FOR OSTEOPOROSIS

This prospective multicenter protocol evaluates the safety, tolerability and efficacy of alendronate, conjugated estrogen and combined therapy to determine if treatment with the combined therapy will produce a significantly greater mean increase in lumbar spine bone mineral density at two years over conjugated estrogen therapy alone in females with postmenopausal bone loss.